The Ohio State University Tobacco Center of Regulatory Science (OSU-TCORS)

OVERALL PROJECT SUMMARY
Nicotine is the most important driver of tobacco use. The tobacco industry's manipulation of nicotine in cigarettes
and smokeless tobacco led to products that were more addictive, abused, and deadly. With “starter” products
for young people and nicotine-naïve users and “mature” products for established tobacco users, the industry has
historically manipulated the “levers” of nicotine concentration and form to increase tobacco use across all
demographics. E-cigarettes (ECs) and more recently oral nicotine pouches (ONPs) vary these nicotine
dimensions signaling that the industry is again following this profit-driven strategy. Recent advancements in
nicotine synthesis also makes nicotine isomer a new product lever that the industry can adjust to drive consumer
uptake through changes in pharmacokinetics and misleading marketing claims. While the US Congress and FDA
have imposed important regulations to dissuade tobacco use among young people, we argue that the regulation
of nicotine itself may be the most effective strategy to achieve optimal population health. Like the tobacco
industry, the FDA can pull these same levers via product standards and marketing regulations to adjust the
appeal and addiction potential of ECs and ONPs. Through our integrative theme, “Flipping the Script”: Using
the Industry's Nicotine Playbook to Maximize Public Health, the Ohio State University Tobacco Center of
Regulatory Science (OSU-TCORS) will be guided by the industry's Consumer Response Model to understand
how nicotine in ECs and ONPs are impacting product appeal, addictiveness, use patterns, and toxicity. We posit
that regulation of nicotine's three dimensions can dissuade young people, including non-users, from using ECs
and ONPs but still provide a satisfying and less harmful alternative for adult tobacco users for complete switching.
Project 1 (P1) and P2 will examine the influence of EC and ONP nicotine manipulations on product appeal,
abuse liability, use, and toxicity; P3, using ONPs as an exemplar product, will examine the influence of nicotine
marketing claims on appeal and product trial; and P4 will examine how young people, including priority
populations, respond to both nicotine product marketing and design characteristics in the natural environment.
The projects are supported by the Market Monitoring Core that will provide critical real-time marketing and
purchasing of products by venue and the Product Evaluation and Manipulation Core that studies products
varied by nicotine dimensions with chemical and toxicological analysis. They also will be supported by the
Administrative Core. The Career Enhancement Core will foster the training of students, postdoctoral fellows,
and early career investigators in tobacco regulatory science. Together, the OSU-TCORS addresses the FDA
priority scientific domains of Product Composition and Design, Toxicity, Addiction, Health Effects, Behavior, and
Marketing Influences. The projects are highly integrated and will provide the FDA with critical, first-of-its-kind
data by conducting complementary interventional and observational studies to inform the Consumer Response
Model as a tool to protect public health.

Public health relevance
OVERALL PROJECT NARRATIVE The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.